Integrated Care for Hepatitis C: Current Uptake & Impact on Future Treatment

PROJECT SUMMARY/ABSTRACT
In this proposal for a K01 Mentored Research Scientist Development award, Shashi Kapadia, MD MS
proposes a training and research program that will enable him to become an independent physician-researcher
focused on policy and systems factors that impact drug user health. Dr. Kapadia is currently an Instructor in
Medicine in the Division of Infectious Diseases at Weill Cornell Medicine whose research focuses on hepatitis C
(HCV) treatment access for people who inject drugs (PWID).
To achieve his long-term goal, Dr. Kapadia will obtain skills in evaluating care delivery models that
integrate medical and behavioral health care, particularly the care of substance use disorders. He will learn
methodological approaches to policy research that include natural experimental designs and analysis of
administrative/claims data, conducting mixed-methods research, and using simulation models to predict the
impact of public health interventions. He will achieve these training objectives with a combination of formal
coursework, rotations in diverse care settings, mentorship, and hands-on research experience. He will be
mentored by Dr. Bruce Schackman (primary), Dr. Yuhua Bao, Dr. David Perlman, Dr. Kristen Marks, and Dr.
Erika Martin, as well as a team of expert consultants. Combined, these individuals have expertise in all of the
training areas that Dr. Kapadia seeks to develop during this award period.
The population health problem that Dr. Kapadia will study during the proposed career development
award is the need to improve access to HCV treatment for PWID, with a focus on New York State. Expanded
treatment access is needed to prevent long-term morbidity and mortality from liver disease, and can potentially
eliminate HCV transmission. Integrating HCV treatment into primary care and substance use treatment
settings may help alleviate barriers to expanded treatment. In his proposed research, Dr. Kapadia will use data
from New York State Medicaid to study trends in HCV treatment uptake in primary care (Aim 1). He will
conduct interviews to contextualize these quantitative findings, and to elicit factors that would further support
treatment integration into primary care, substance use treatment, and syringe service programs. (Aim 2). He
will then develop a simulation model, based on these findings, to forecast the impact of integrated care models
on HCV treatment of PWID in New York State (Aim 3).
The proposed research will test whether integrated HCV care is being effectively utilized, describe the
barriers to achieving it, and analyze its impact on the health of HCV-infected individuals, especially PWID. It
will be relevant to policymakers and public health practitioners. Additionally, the skills that Dr. Kapadia will
gain through completion of this mentored research and training plan will enable him to seek future R01
funding and achieve his goal of becoming an independent investigator.

Public health relevance
PROJECT NARRATIVE Hepatitis C (HCV) treatment for people who inject drugs (PWID) can eliminate transmission of HCV and prevent HCV-associated complications and deaths, but the ideal strategy for scaling up treatment delivery is not known. This project aims to study how HCV treatment of PWID is being integrated into primary care and substance use treatment settings, and the impact that further integration would have on HCV treatment. The results will identify effective approaches to promote HCV treatment uptake among PWID.